Methods for measuring matrisome molecule similarity during disease processes

Project Summary/Abstract:
The application responds to NIGMS PAR-19-367 “Maximizing Investigators' Research Award (R35 - Clinical
Trial Optional)”
My research group focused initially on analytical methods for glycosaminoglycans (GAGs). These linear,
sulfated polysaccharides are attached to serine residues of proteoglycan molecules found on cellular surfaces,
in intracellular granules and in extracellular matrices. Binding interactions between GAGs and proteins are
central to aspects of animal physiology including cellular signaling, the cellular microenvironment, and host-
host, and host-pathogen recognition. My group developed methods for liquid chromatography-mass
spectrometry analysis and sequencing of GAGs, extraction of GAGs from wet tissue and tissue slides, and
bioinformatics programs for interpretation of GAG MS and tandem MS data. We then pioneered methods to
acquire glycomics (GAGs and N-glycans) and proteomics from biospecimen tissue slides. We applied these
methods to study of neurological aging, cancer, neurodevelopmental, and neurodegenerative diseases.
As funded through NIGMS R01GM133963 “Methods for determination of glycoprotein glycosylation similarities
among disease states”, my group is developing analytical and bioinformatics methods for glycoproteomics of
the extracellular matrix molecules (known as the matrisome) of brain. The primary focus has been on
glycoproteomics MS acquisition methods and bioinformatics for rigorous statistical determination of molecular
similarities for matrisome molecules and how these change during normal aging versus disease processes.
I now propose to expand our brain glycoproteomics molecular similarity scope to include characterization of
GAGs that modify specific matrisome molecules. Our goals will be to provide information on the
pathophysiological changes to matrisome molecules that escape detection using traditional antibody-based
detection methods. We will employ a new Omnitrap platform to characterize multiply glycosylated peptides and
peptides modified with GAG chains. We will also exploit the capabilities of ion mobility for measuring molecular
similarities from glycoproteomics data using a Waters Cyclic ion mobility-mass spectrometry instrument. We
will demonstrate these approaches by comparing matrisome molecular similarity among brain regions and as a
function of age.

Public health relevance
Project Narrative The matrisome consists of glycosylated extracellular matrix and cell surface proteins that surround cells and support normal physiological activity. While it is known that glycosylation changes during disease processes, it has not been possible to quantitatively compare glycoprotein structure among biological samples. We aim to develop technologies to meet this need.